BEHAVIORAL TREATMENT OF TRANSIENT MYOCARDIAL ISCHEMIA

The purpose of this study is to investigate the relationship between psychological/behavioral factors and myocardial ischemia, the extent to which behavioral interventions can influence ischemic episodes by reducing stress through exercise or stress management, and the mechanisms through which it happens.